Training Grant on the Biology of Aging

SUMMARY
For the past three decades, the University of Texas Health Science Center at San Antonio (UTHSCSA) has
hosted a premier Training Program in the biology of aging that has resulted in the development of a new
generation of leaders in this field. This application seeks to continue this T32 Training Program and we request
funds to support four predoctoral and four postdoctoral trainees. In this funding period, we are building on our
unparalleled record of success and expand the program to prepare trainees in the emerging area of Geroscience,
term that encompasses (1) fundamentals of basic aging biology; (2) the relationship between aging biology and
the etiology of age-related disease; and (3) principles of translational research in biological aging. Our
overarching objective is to catalyze development of interventions that modulate the aging process, leading to an
extension of healthspan. The achievement of this goal requires a cadre of dedicated young researchers who
have received multi-disciplinary training. Thus, this T32 Training Program aims to attract outstanding young
scientists and train them in a vibrant and collaborative environment rich in Geroscience resources. The Training
Program involves 48 faculty members and takes advantage of the synergies created by their intense
collaborations across 7 departments. Our Geroscience training environment is second to none, and features the
Barshop Institute, a Nathan Shock Center, our new Claude D. Pepper Center, a Geriatric Research, Education
and Clinical Center, and the Interventions Testing Program. Since 1988, this T32 has trained many outstanding
researchers in Geroscience, including current members of the current T32 Faculty. Our former trainees have
been awarded numerous federal grants (including F, K and R series awards), and include Assistant or Associate
Professors. Drs. Nicolas Musi, Peter Hornsby and Veronica Galvan will co-direct this Program and are supported
by an Internal Steering Committee and an External Advisory Committee. The Faculty expertise crosses the
spectrum of aging biology (inflammation, senescence, metabolism, epigenetics, macromolecular damage,
proteostasis, stem cells); genesis of age-related diseases (cancer, diabetes, Alzheimer's disease, osteoporosis,
sarcopenia); and early-phase translational research. The principal components of the Training Program are: (1)
participation with graded responsibility in the laboratory of an experienced investigator; (2) commitment to
collaboration and the use of multidisciplinary research approaches; (3) continuing research-in-progress
seminars; (4) integrated lecture/journal club series on Geroscience; (5) courses and seminars in the responsible
conduct of research, scientific communication, grantsmanship and peer review; (6) a rigorous group mentoring
design; (7) preparation of an individual development plan and comprehensive evaluation of trainee progress; (8)
continued evaluation and teaching of mentoring skills for faculty preceptors; and (9) active recruitment of
meritorious trainees and faculty preceptors to reflect workforce ethnic/racial diversity. Trainee access to on-going
departmental conferences, clinical rounds and courses further enhances the training experience.

Public health relevance
NARRATIVE - PUBLIC RELEVANCE The number of senior citizens is expected to almost double and to comprise more than 20 percent of the U.S. population by the year 2050. Therefore, there is an urgent need to accelerate the development of strategies that will improve the health of our citizens as they age. The achievement of this goal requires the formation of a strong body of motivated young researchers with outstanding training in aging research.